Mitochondrial regulation of chemotherapy-induced reactive myelopoiesis and pro-metastatic effects

Recent studies and our preliminary data highlight the importance of myelopoiesis in the chemotherapy
induced accumulation of immunosuppressive myeloid cells. Growing evidence also demonstrates the
ability of hematopoietic stem and progenitor cells (HSPCs) to sense inflammation, ultimately regulating
HSPC proliferation and differentiation via metabolic alterations. It’s known that mitochondrial oxidative
phosphorylation (OXPHOS) results in an increase of reactive oxygen species (ROS) production in HSPCs.
However, our understanding of inflammation, metabolic alterations of HSPCs, and monocyte development
is still limited. Current antioxidant strategies are not clinically effective. Finding novel targets could provide
better therapeutic efficacy for combination therapy with chemotherapy. Mitochondria are the main source
of ROS and are highly dynamic through the fission and fusion events, and dynamin-related protein 1 (Drp1)
is an essential mediator of mitochondrial fission that elicits excessive ROS production. Importantly,
targeting of excessive mitochondrial fission can regulate hematopoiesis via the mechanisms beyond ROS.
The objective of this project is to determine whether mitochondrial ROS and Drp1 mediated HSPC
mitochondria fission control chemotherapy induced reactive myelopoiesis and pro-metastatic effect. We
hypothesize that chemotherapy induces reactive myelopoiesis by enhanced ROS production and Drp1-
mediated mitochondrial fission in HSPCs, which drive the expansion of pro-metastatic monocytes. Further,
targeting of mtROS or Drp1 reduces chemotherapy-induced metastases by regulating reactive
myelopoiesis and monocyte phenotype. We will test our hypothesis by completing the following two specific
aims: (1) Determine chemotherapy induced mitochondrial metabolism in HSPCs and phenotypic changes
of monocytes, and (2) Determine whether targeting of Drp1 dependent mitochondrial fission reduces
chemotherapy induced pro-metastatic effect. The proposed study is significant, because it will reveal a
novel mechanism by which chemotherapy induces HSPC mitochondrial fission leading reactive
myelopoiesis and pro-metastatic monocyte development. The discovery of role for mitochondrial fission in
HSPCs after chemotherapy will stimulate new approach to improve anti-tumor efficacy of conventional
chemotherapy.

Public health relevance
NARRATIVE: This proposal addresses roles of mitochondrial ROS and Drp1 dependent mitochondrial fission in chemotherapy-induced reactive myelopoiesis and the pro-tumor monocyte development. This proposal also addresses whether targeting of mitochondrial ROS or Drp1 reduces chemotherapy-induced pro-metastatic effect. The objective of this proposal is consistent with the goals of the NCI R21 program and will have a significant impact on public health by providing approach for prevention of tumor metastasis.